Administrative Supplement: Construction and Application of Research-Grade Cohorts from EHR for Metabolic Dysfunction-Associated Cancer Research

ABSTRACT
This application is being submitted in response to "Administrative supplements to advance development of
transdisciplinary and large-scale population science and cancer control research projects”.كWe propose a one-
year supplement to build scalable infrastructure and analytic tools to support transdisciplinary research on
metabolic dysfunction-associated cancers (MDAC)—a growing category of malignancies such as breast,
colorectal, prostate, and lung cancers, driven by metabolic abnormalities beyond obesity. While obesity has
traditionally been the focus of cancer prevention efforts, emerging evidence highlights that metabolic
disturbances such as hyperglycemia, dyslipidemia, insulin resistance, and systemic inflammation independently
contribute to cancer risk. These mechanisms have prompted growing interest in the potential of GLP-1 receptor
agonists (GLP-1RAs)—a class of anti-diabetic agents with pleiotropic effects on weight, insulin sensitivity, and
inflammation—as novel interventions in cancer prevention. However, critical gaps remain in understanding their
long-term impact on cancer outcomes, particularly for patients with type 2 diabetes and metabolic dysfunction.
Existing real-world datasets such as administrative claims and cancer registries lack detailed metabolic data and
are limited by reporting lags. While multi-institutional electronic health record (EHR) database offers greater
clinical granularity, it also suffers from partial observation bias due to fragmentation of health systems. To address
this, we propose leveraging the EPIC COSMOS database, a nationwide EHR platform covering over 295 million
U.S. patients, to advance data science tools that enable robust MDAC research. Our Aim 1 will adapt a machine
learning–based algorithm previously developed to identify a cohort of “loyal patients” in COSMOS who receive
care in ZIP codes with near-complete market penetration. We will validate MDAC incidence captured in
COSMOS against two state cancer registries to ensure completeness and reliability. In Aim 2, we will use the
validated “loyal patient” cohort and emulate a target trial to evaluate the effect of newer GLP-1RAs (e.g.,
semaglutide, tirzepatide) on MDAC incidence among patients with type 2 diabetes. This supplement will lay the
foundation for future extramural grant submissions by establishing EPIC COSMOS as a research-grade platform
for large-scale, population-based cancer control studies and pharmacoepidemiologic evaluations focused on
modifiable metabolic risk factors and cancer outcomes.

Public health relevance
Project Narrative Metabolic dysfunction-associated cancers (MDAC), including breast, colorectal, pancreatic, and other cancers, are increasingly linked to metabolic abnormalities such as insulin resistance, hyperglycemia, and systemic inflammation, yet remain understudied in cancer control research. This project will use EPIC COSMOS, one of the largest electronic health record databases in the United States, to develop and validate an analytic pipeline that establishes a research-grade platform for MDAC investigation and evaluates the impact of GLP-1 receptor agonists (GLP-1RAs) on MDAC incidence. The findings will inform future population-based studies and support more effective, data-driven strategies to reduce cancer burden in patients with metabolic dysfunction.